Core A: Administrative and Biostatistics Core

PROJECT SUMMARY – ADMINISTRATIVE AND BIOSTATISTICS CORE (CORE A)
The overall goals of the Administrative and Biostatistics Core (Core A) are to 1) continue to provide a structure
to facilitate effective interactions toward the accomplishment of the aims of this Program Project and specifically
to foster and promote the goals of the Program and each component (cores and projects) by providing scientific
direction, administrative and budgetary support, oversight, integration of program activities and the industrial
partner, and ensuring operational efficiency; and 2) to continue to provide biostatistics and other statistical
support for the P01. The following are the objectives of Core A: 1) provide research direction by setting the
research agenda focused on the discovery of novel chemicals from selected tropical rainforest plants, as well as
lichens, cyanobacteria and filamentous fungi, for development as cancer chemotherapeutic agents, particularly
for tumors not cured by present treatment methods. 2) Ensure operational efficiency for Program components
by providing centralized grant administration, information dissemination, budget data processing, and exchange
of information and services. 3) Promote integration of the Research Projects and Cores to promote interaction
among the three primary universities represented by the investigators, and relevant external entities and 4)
provide biostatistics support for the three Projects and the two Cores of the P01 Program. Core A will continue
to ensure that all components of the Program work seamlessly together to accomplish the overall and specific
project goals of the P01 Program.